DP24-004, PRC Core: UCSF Prevention Research Center: Reducing social isolation among older LGBTQ+ adults

To respond to the epidemic of loneliness and social isolation among LGBTQ+ adults, we propose a Prevention
Research Center (PRC) at the University of California, San Francisco (UCSF) that facilitates significant and
innovative health science research through partnerships with public health colleagues that ultimately improves
community health. Improving social connectedness among older adults is an important health problem
prioritized in the PRC funding announcement RFA-DP-24-004 and for which, we have significant capacity to
address. Certain communities continue to be disproportionately impacted by loneliness and isolation, including
LGBTQ+ (lesbian, bisexual, gay, transgender, queer/questioning, and other sexual and gender minority) older
adults. Older LGBT+ adults often experience worse health than their heterosexual/ cisgender peers, and, although
evidence-based interventions to improve social connectedness among older LGBTQ+ adults have been tested in
research environments, their scale up is urgently needed in community settings.
The UCSF PRC is uniquely positioned to improve social connectedness among older LGBTQ+ adults because we
have an experienced, innovative, and multi-disciplinary team of world-renowned geriatricians who have
developed, implemented, and evaluated evidenced-based, peer-support interventions for older adults and who
have existing relationships with community groups who can do the work of adapting and replicating these
interventions in broad and diverse community settings.
Our overall aims are to: (1) Maintain the multi-disciplinary, productive, vibrant, and innovative UCSF PRC to
further catalyze high-quality applied prevention research; (2) Collaborate with partners to disseminate and
translate research findings into practice, especially within the LGBTQ+ community; (3) Leverage the work of
our community partnerships, dissemination and translation efforts, and evaluation cores to reduce health
disparities and strengthen public health programs and practice; (4) Conduct a dissemination and
implementation core research project, using a community engaged approach, to improve social connectedness
among older LGBTQ+ adults; and (5) Participate in the PRC network to (a) inform our core research project
and center activities; (b) advance the network's collective impact; (c) serve as a resource to other PRCs; and
(d) adapt, implement, evaluate, disseminate, and translate evidence-based public health interventions.
The PRC will include an administrative infrastructure, a community engagement core, a dissemination and
translation core, and an evaluation core. The work of the cores will be leveraged to increase health equity
among LGBT+ older adults and strengthen public health programs and practice.

Public health relevance
In order to address health inequities among LGBTQ+ older adults caused by loneliness and isolation, the UCSF PRC will work to improve social connectedness among LGBTQ+ older adults. We will strengthen community engagement and collaboration processes and support the implementation of evidence-based interventions, especially the Peer Outreach Program. The UCSF PRC will also translate and disseminate prevention science, train students, public health professionals and community members on the importance of social connection for LGBTQ+ adults in accordance with the Surgeon General's 2023 Call to Action, as well as continually evaluate its activities and participate in the PRC Network.